Characterizing the impact of Yersinia Pestis to the phenotypic evolution of the human immune system

Project Summary
Pathogens are one of the strongest selective pressures on the human genome. As modern humans
migrated out of Africa, they encountered markedly different pathogenic environments, likely resulting in
population-specific selection of immune phenotypes. Consistent with this hypothesis, some of the most
compelling evidence for local positive selection in the human genome has been detected among genes
involved in immunity and host defense. Yet, our understanding of the role that local adaptation plays in
shaping phenotypic variation in immune responses across populations is still in its infancy. To better
understand the complex relationship between pathogens and host adaptation we propose to study the
selective impact on the immune system of one of the most devastating pathogens in history – Yersinia pestis,
the agent of the Black Death. Since its emergence in Eurasia 1500 to 6400 years ago Y. pestis has swept
Eurasia and North and Central Africa in two major pandemics (Justinian, 541-544; Black Death, starting 1347-
1351) and has subsequently spread nearly worldwide via a third ongoing pandemic. Although Y. pestis is
proposed to have severely culled the Eurasian population, how groups that differ in their historical exposure to
plague respond to the pathogen is not known. Addressing this gap is not only important for understanding the
recent evolution of the human immune system, but may also help reveal the molecular basis of ancestry-
related differences in susceptibility to infectious diseases, chronic inflammatory disorders, and autoimmune
disorders. Using combined expertise in human genomics, immunology, infectious diseases and ancient DNA,
we propose: (i) to characterize inter-individual and inter-population variability in immune responses to infection
with Y. pestis; (ii) to map expression quantitative trait loci (eQTLs) that are associated with variation in
response to infection with Y. pestis; and (iii) to identify genetic loci showing signatures of positive selection by
Y. pestis by looking at “real-time” fluctuations in allele frequencies among immune-related genes and
immunological QTLs sequenced from skeletal remains of European populations living before, during, and after
the Black Death. This work is expected to yield unprecedented insight into the genetic mechanisms associated
with increased protection against Y. pestis as well as reveal novel genetic markers involved in the susceptibility
to and/or protection against contemporary infectious diseases

Public health relevance
Project Narrative Yersinia pestis – the causative agent of Black Death – has been posited to be one of the strongest agents of pathogen-mediated selection in human history. This project uses a unique combination of functional genomics immunology and ancient DNA tools to investigate the genetic basis an evolutionary underpinnings of inter- individual and ancestry-associated differences in immune response to Yersinia pestis infection.